Global post-transcriptional regulators in P. aeruginosa

Abstract
Pseudomonas aeruginosa is an important opportunistic pathogen of humans. It is the principal cause of
morbidity and mortality in Cystic Fibrosis (CF) patients, a major cause of hospital-acquired pneumonia and is
particulary problematic in burn wound infections. Hfq is a conserved global post-transcriptional regulator that is
required for the virulence of P. aeruginosa. In other organisms Hfq is best known for its ability to promote the
base-pairing between small regulatory RNAs (sRNAs) and their target transcripts. Hfq-promoted interaction
between an sRNA and its mRNA target typically functions to repress translation of the target, although Hfq can
also inhibit translation in an sRNA-independent fashion. We have found that in P. aeruginosa Hfq associates
with hundreds of transcripts as they emerge from RNA polymerase. Because transcription and translation are
coupled in bacteria, the interaction of Hfq with these nascent transcripts presumably allows this RNA-binding
protein to exert its regulatory effects on translation at the earliest possible opportunity. In Aim 1 we propose to
identify the targets of all the sRNAs that interact with Hfq in P. aeruginosa and determine whether these
sRNAs frequently work in conjunction with Hfq on nascent transcripts. The interaction of Hfq with nascent
transcripts has important implications for how transcript abundance can be controlled; specifically, Hfq-
dependent inhibition of the translation of nascent transcripts would render them accessible to the transcription
termination factor Rho or to ribonucleases. In Aim 1 we will determine whether Hfq reduces the abundance of
those nascent transcripts it binds through effects on Rho-mediated transcription termination or through effects
on RNA degradation. We have found that a second global post-transcriptional regulator in P. aeruginosa called
RsmA also targets hundreds of nascent transcripts, including many of those that are targeted by Hfq. RsmA is
a key regulator of the switch between acute and chronic infection phenotypes in P. aeruginosa and in Aim 2 we
will investigate whether Hfq and RsmA modulate each other’s activities through competition or cooperation on
common targets. Like Hfq, the binding of RsmA to target mRNA species typically inhibits their translation. In
Aim 3 we propose to determine whether the interaction of RsmA with nascent transcripts influences their
abundance through effects on Rho-mediated transcription termination or effects on RNA degradation. The
experiments outlined in this proposal are expected to illuminate how Hfq and RsmA control gene expression
through their widespread targeting of nascent transcripts. The co-transcriptional activities of these global post-
transcriptional regulators have been underexplored and our proposed studies may have implications not only
for how Hfq and RsmA impact the virulence of P. aeruginosa, but also for how their orthologs influence
virulence gene expression in other pathogenic bacteria that contain them.

Public health relevance
Narrative Pseudomonas aeruginosa is an important opportunistic pathogen that is the principal cause of morbidity and mortality in cystic fibrosis patients and one of the most common causes of ventilator-associated and hospital-acquired pneumonia. Our studies are expected to reveal how two post-transcriptional regulators that are essential for the virulence of this organism control the expression of target genes. This work has the potential to reveal novel therapeutic targets for the prevention and treatment of P. aeruginosa infections.